Development of the waixenicin A pharmacophore as a therapeutic intervention for neonatal hypoxic brain injury

PROJECT SUMMARY/ABSTRACT
Neonatal and perinatal hypoxic-ischemic brain injury (HIBI) is a major cause of acute mortality and chronic
neurological morbidity in infants and children occuring in 2% of full-term infants and approaches 60% in
premature infants. 20% to 50% of asphyxiated newborns die. Among the survivors, up to 25% show permanent
neuropsychological handicaps such as cerebral palsy, generating lifetime costs to the US healthcare system at
an estimated $11.5 billion USD. Therapeutic hypothermia was the first evidence-based neuroprotective
therapy for neonates with hypoxic-ischemic encephalopathy (HIE) and has become the clinical standard of care
(SOC). Despite reducing the combined rate of death and disability, therapeutic hypothermia has to be initaited
within 6 hours of HIE, a very narrow diagnostic window. Neonates diagnosed within this time frame are treated
with hypothermia for 3 days. Currently about half of hypothermia-treated HIE neonates experience adverse
outcomes with personal and socioeconomic implications. Clearly, there is an unmet need for adequate
therapeutic interventions against HIBI beyond current SOC. The divalent ion channel-kinase fusion protein
TRPM7 controls critical cellular processes involved in ischemic events, including experimental HIBI, and
is a biologically logical and highly promising target for drug development, particularly in light of the discovery of
a highly selective and potent inhibitor, waixenicin A (WaixA). This provides an excellent starting point to
develop semi-synthetic derivatives of WaixA with improved pharmacological properties towards therapeutic
intervention in HIBI.
Due to the established
involvement of TRPM7
in hypoxia and WaixA
effectiveness in HIBI, we
hypothesize that semi-
synthetic waixA
derivatives protect
against HIBI; that semi-
synthetic analogs of WaixA covalently bind to TRPM7; and that, based on its excellent predicted blood-brain-
barrier properties, optimized semi-synthetic analogs of waixA with improved physiochemical properties can serve
as therapeutic leads against HIBI.
To address the above, our interdisciplinary IGNITE team proposes to employ a combination of
complementary approaches that rest on our respective core expertises and competencies: (1) Semi-
synthetic optimization of WaixA analogs through proposed derivatization of isolated WaixA (R61); (2) Potency,
selectivity, ADME and safety screens of semi-synthetic waixenicin derivatives in vitro through a Medicinal
Chemistry Screening Cascade and selection of 3 WaixA analogs as lead compounds for in vivo work (R61); (3)
Therapeutic validation of these 3 qualifying semi-synthetic waixenicin derivatives in an established mouse model
of neonatal hypoxic-ischemic brain injury (HIBI) in vivo (R61 and R33) to ulitmately enable transition to Blueprint.

Public health relevance
PROJECT NARRATIVE Neonatal and perinatal hypoxic-ischemic brain injury (HIBI) is a major cause of death and neurological damage in infants and children, and there is an unmet need for therapeutic options to prevent or reverse these effects. The plasma membrane protein TRPM7 is known to control critical cellular processes involved in oxygen- deprivation of the brain and to protect the brain from damage when suppressed, and the only known specific and potent inhibitor of TRPM7 is waixenicin A. The current proposal engages an interdisciplinary team to lay the groundwork for a viable therapeutic treatment option developed from waixenicin A based on this mechanism.